LJP 394 ADMINISTERED TO PATIENTS WITH SYSTEMIC LUPUS ERYTHEMATOSUS

Assess the linearity of kinetics and dose proportionality over an intravenous dose range and evaluate the effect of intravenous dosing regimen on concentrantions of anti-dsdna antibody (surrogate for clinical efficacy).